Impact of phagocytosis on amyloid beta-induced pathology

IMPACT OF PHAGOCYTOSIS ON AMYLOID BETA-INDUCED PATHOLOGY
Abstract
Alzheimer's disease (AD) is a devastating neurodegenerative disease that impacts more than 6 million
Americans and millions more Worldwide. Despite years of active research, our understanding of this disease is
incomplete, and the patient population remains without effective therapeutic options.
In AD, clearance of apoptotic neurons and amyloid-beta aggregates is reduced, as microglia become
overloaded with chronically phagocytosed debris. The current dogma suggests that decreased clearance of
apoptotic cells, also known as “efferocytosis”, inevitably leads to pathology. However, our preliminary data
suggest that this concept warrants further testing. We show here that pharmacologic or genetic efferocytosis
reduction (not complete ablation) can reduce inflammation in mouse models of inflammatory arthritis and kidney
injury, suggesting unexpected benefits of reduced clearance in inflammation.
In this proposal, we will test the hypothesis that reduced efferocytosis alleviates amyloid-beta induced
pathology through enhanced debris processing/degradation (due to reduced load of phagocytes such as
microglia). We will pursue the following aims: 1. Using mice with genetic decrease in efferocytosis due to the
combined loss of four different efferocytosis receptors, we will test debris (apoptotic cells, amyloid-beta
aggregates, myelin debris) clearance, processing, and response of microglia ex vivo. 2. By crossing these mice
with the mouse model of amyloid-beta induced pathology and Alzheimer's disease (5xFAD mice), we will quantify
multiple disease parameters, determine the numbers of apoptotic cells in the brain, and analyze the microglial
response in the reduced clearance environment in vivo.
Our proposal is innovative because we will challenge the dogma that reduced efferocytosis is universally
detrimental. Our proposal is significant because these studies will provide new knowledge to the community
about the contribution of efferocytosis to AD pathology and provide new avenues to therapy in AD.

Public health relevance
Narrative: This proposal is aimed at exploring whether reduced clearance of dying cells (a process called “efferocytosis”) and debris material could alleviate pathology in a mouse model of Alzheimer's Disease. Based on our preliminary evidence, we hypothesize that reduced efferocytosis will decrease the clearance overload of microglia (cells that perform efferocytosis), allowing them to process the cargo more efficiently. We hope that our research proposed here will offer new avenues to promoting neuroprotection and delay or eliminate the irreversible cognitive decline currently facing Alzheimer's Disease patients.